Implementation of Confidential Care to Increase Adolescent HIV Testing in Pediatric Primary Care Settings

PROJECT SUMMARY/ABSTRACT
In the United States, adolescents are the age group least likely to be aware of their HIV infection and linked to
care in a timely manner, contributing to disproportionately low rates of viral suppression and increased risk of
transmitting HIV to others. HIV testing is a cornerstone to HIV prevention, but uptake among adolescents is
lagging. Adolescents who receive confidential care (i.e., have time alone with a health care provider during visits,
the ability to self-consent to services, and the privacy of their health information maintained) are significantly
more likely to engage in important discussions about sexual health issues, disclose sensitive sexual health
information, receive appropriate sexual health services (e.g., HIV testing), and return for care. However, despite
guidelines from professional medical organizations recommending universal access to confidential sexual health
services, it is estimated that less than half of adolescents – the majority of whom are served in pediatric primary
care settings – receive confidential care. Structural interventions targeting aspects of the environment that serve
as barriers to HIV prevention offer an opportunity to increase adolescent HIV testing uptake by addressing the
shortcomings of the systems in which sexual health services are delivered. This research will consider the
perspectives of pediatric primary care patients, providers, and clinic leadership to develop a multicomponent
structural intervention to increase adolescent HIV testing uptake by improving the implementation of confidential
care as standard practice in pediatric primary care settings. This study will draw from the principles of community-
based participatory research (CBPR) and utilize a multiphase optimization strategy to achieve the following
specific aims: (1) explore patient preferences about how confidential care is provided in pediatric primary care;
(2) examine provider- and organizational-level barriers and facilitators to implementing confidential care as
standard practice in pediatric primary care; and (3) pilot test the feasibility and acceptability of structural
intervention components to increase adolescent HIV testing uptake by improving the implementation of
confidential care as standard practice in pediatric primary care. Consistent with the NIMH strategic plan goal to
“strive for prevention and cures” by “optimizing the effectiveness of interventions for delivery in practice settings,”
this Mentored Research Scientist Development Award (K01) will lay the groundwork for addressing health
inequities among adolescents through structural interventions with high capacity for real-world implementation
and dissemination. Through a combination of mentorship from a multidisciplinary team of experts at Yale
University, coursework/workshops, experiential learning through the proposed research, and professional
development activities, this K01 will provide Dr. Aivadyan with essential training in: (1) CBPR; (2) structural
intervention development; (3) implementation science; and (4) the responsible conduct of research with children.
This advanced training will position Dr. Aivadyan for a successful career as an independent investigator
committed to promoting health equity by improving access to high-quality sexual health services for adolescents.

Public health relevance
PROJECT NARRATIVE In the United States, age-based inequities in access to confidential HIV testing are a major barrier to reducing the incidence of improve the implementation of clinical guidelines on confidential care as standard practice in pediatric primary care settings, thereby increasing HIV testing uptake among adolescents. The research and training in this application will prepare the candidate for an independent scientific career addressing health inequities among adolescents through structural interventions with high capacity for real-world implementation and dissemination. of HIV and associated negative health outcomes among adolescents. Informed by the perspectives pediatric primary care patients, providers, and clinic leadership, this research will